DOSE-RANGING STUDY OF DIPRAFENONE HYDROCHLORIDE FOR VENTRICULAR ECTOPY

Considerable experience has been accumulated at this center with the new antiarrhythmic agent propafenone, a sodium channel blocker with important ancillary beta blocking activity. This protocol will evaluate the clinical pharmacology of a propafenone analog, diprofenone, which, in in vitro studies has greater beta blocking potency than propafenone.